Investigation of a novel prelimbic cortical peptidergic population in binge drinking behavior

Project Summary Alcohol Use Disorder (AUD) is a chronic brain disease with major health and societal concerns resulting in more deaths than any other type substance misuse. Of all the forms of alcohol misuse, binge drinking is the most common, costly, and deadly pattern of excessive alcohol use. Addressing this major public health problem requires a better understanding of the underlying neurobiology of binge drinking. One region of particular interest for binge-drinking is the prelimbic cortex (PL). We have previously shown that excitatory and inhibitory signaling in the PL is altered following a variety of models of ethanol exposure. In addition, our preliminary data indicates that somatostatin neurons in the PL are involved in alcohol binge drinking in both sexes. This is particularly novel as it represents a promising neuronal population capable of reducing binge drinking behavior. Our project will (1) investigate how PL somatostatin neurons interact with other neurons (synaptic connectivity and signaling), and (2) what role they play in binge drinking (chemogenetic activation and inhibition). Taken together, these experiments will assess the hypothesis that somatostatin neurons in the PL are a promising therapeutic target for alcohol use disorder, and binge drinking in particular.

Public health relevance
Project Narrative This project will investigate the involvement of a specific population of neurons in binge drinking behavior. We will assess how these neurons connect with other neuronal populations, how they signal, and their role in a mouse model of alcohol binge drinking. This work will provide key insights into the neurobiological underpinnings of binge drinking—a major public health problem—and support efforts to develop treatments for reducing alcohol use disorder (AUD).